SC INBRE Administrative Core

Project Summary – Administrative Core
To further expand the reach of SC INBRE across South Carolina, in the next phase the SC INBRE network will
grow to include three Comprehensive Research Universities and eleven Primarily Undergraduate Institutions,
as well as four Outreach/Alumni institutions. Key to the effectiveness and success of such a large network will
be the Administrative Core. The Administrative Core, working with the Steering Committee, External Advisory
Committee, and Bioinformatics Core, will play a pivotal role in bringing together all of the participating INBRE
institutions to create a dynamic biomedical research environment within South Carolina. The overall structure
of the Administrative Core will remain as it currently is composed of the Program Director, Program
Coordinator, the Program Manager, and a Communication Manager. The Administrative Core will manage all
aspects of SC INBRE IV including organization and logistics of the DRP and Bioinformatics Pilot Project
programs, the Academic Career Development and Leadership workshop, in addition to providing assistance,
support and oversight to the institutional SC INBRE programs at each network member institution. This Core
will work with the Steering Committee to monitor and evaluate the progress of each SC INBRE funded faculty
member and all students trained by SC INBRE. The Administrative Core will ensure the formal annual
evaluation of SC INBRE conducted by the Program Evaluator, the External Evaluation Team, and the External
Advisory Committee (EAC). The Administrative Core will continue to provide logistical support for the
Bioinformatics Core, organizing the review of Bioinformatics Pilot Project and Student-Initiated Research
Projects while providing assistance with the organization of training courses and workshops. The Core will
continue to support pipeline development activities, including the Research Experiences for Teachers program
established in earlier phases of SC INBRE which provides research opportunities and curricular activities to
teachers that they can use in their classrooms to introduce high school students to biomedical careers. The
Administrative Core will see that SC INBRE continues to expand opportunities for a diverse student population
to participate in biomedical research. Each network institution developed a diversity plan as a component of
their application for membership in the SC INBRE network. The Administrative Core will actively work with the
EAC to carefully monitor the progress of all network institutions in this area to ensure that the leadership at
each institution maintains a strong focus on increasing participation of underrepresented minority and
underserved students in their research programs.